Training in Visual Neuroscience

DESCRIPTION (provided by applicant): This is a competing renewal application for funds to support pre- and postdoctoral training in visual neuroscience at New York University in the Center for Neural Science (CNS) and the Cognition and Perception Program in the Department of Psychology (CP). We seek to renew training support for 6 pre-doctoral and 2 postdoctoral fellows. This level of support is justified by the need for the training program to provide for the training of a diverse yet coherent group of trainees. With the help of previous NEI support, the Visual Neuroscience Training Program has become a leading center for research training and has launched and shaped the careers of many who have made important contributions to the field. The 17 faculty of the training program seek to understand the visual system from a variety of disciplinary perspectives, but all share a consistent focus on understanding visual function. The quality, experience, breadth, and productivity of the training faculty have in the past and wil in the future provide a fertile intellectual environment in which young scientists can thrive. Thre newly recruited faculties have invigorated the program and made it even better. There is ample instruction through courses and especially through mentoring in the research labs of CNS and CP that helps bring trainees to the frontiers of vision research. Many active researchers supported by NEI and other agencies provide direction, leadership, and support for students once they emerge as more independent senior scholars. Extensive shared facilities, including MRI scanners, an MEG and a TMS facility operated solely for research the two participating departments; facilitate collaborations among faculty and trainees. The students who join the CNS and CP doctoral programs are of outstanding quality and a very high proportion have historically gone on to successful and in some cases stellar careers in visual neuroscience.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project will train researchers in vision research, to provide the next generation of advances that will fuel national and international research progress in the visual sciences. The trainees will enhance our understanding of visual function and enable remediation of disabling diseases of the eye and central visual system.